Defining new pathways for cardiac automaticity

Project Summary
Cardiac arrhythmias are a major cause of mortality in heart disease. Patients harboring loss-of-function
variants in the ankyrin-B (AnkB) gene (ANK2) display severe and complex cardiac phenotypes, including sinus
node dysfunction, atrial fibrillation (AF), heart rate variability (HRV), conduction defects, catecholaminergic
polymorphic ventricular arrhythmia (CPVT), and/or sudden cardiac death. Moreover, previous studies have
shown that common ANK2 gene variants in the general population are associated with QTc alterations and
ventricular arrhythmia susceptibility, and that AnkB levels are altered in large animal models of cardiovascular
disease. While these studies have provided important insight into arrhythmia mechanisms in common and
acquired forms of disease, they have also identified important gaps in our understanding regarding control of
heart rate and rhythm by the autonomic nervous system. Given the importance of abnormal autonomic control
in cardiac arrhythmia and disease, it is essential to understand the underlying molecular pathways important for
targeting of key membrane receptors/channels.
This K99/R00 proposal focuses on new roles and mechanisms underlying ion channel/membrane protein
regulation in human cardiac automaticity. This K99/R00 proposal covers unexpected, but directly related areas
of arrhythmia biology, each directly integrating clinical, translational, and mechanistic platforms. This proposal is
based on clinical and molecular data demonstrating a key and unexpected role of AnkB in regulating the
assembly and targeting of the two IKACh channel subunits G-protein-activated inwardly rectifying (GIRK1 and
GIRK4) that regulate cardiac `fight or flight' responses as well as atrial excitability in response to cholinergic
stimuli. We identified direct AnkB/GIRK interactions and uncovered patients with arrhythmias harboring GIRK4
variants that block the interaction. As atrial arrhythmias and inappropriate heart rate are independent predictors
of cardiovascular mortality and IKACh dysregulation is a major hallmark of atrial arrhythmias, these findings will
have impact on both congenital and acquired forms of human atrial disease. We hypothesize that ankyrin-B
plays a key unrecognized role regulating the molecular targeting and stabilization of GIRK4/GIRK1 in atria and
sinoatrial node tissue, thus controlling sympathetic/parasympathetic balance to tune the heart rate. We further
hypothesize that dysfunction in the ankyrin-B pathway due to reduced ankyrin-B expression or human ankyrin-
B loss-of-function variants results in loss of GIRK subunit regulation and altered cardiac automaticity. We will 1)
Identify molecular mechanisms for GIRK1/GIRK4 assembly and membrane targeting; 2) Identify novel roles for
AnkB-based pathways in GIRK/IKACh & autonomic regulation; 3) Define roles of AnkB/GIRK4 complex in human
atrial myocytes at baseline & in disease.

Public health relevance
Project Narrative Cardiac arrhythmias are a major cause of mortality in heart disease, and are the basis for more than a quarter of a million deaths annually in the U.S. alone. This proposal will focus on new roles and mechanisms underlying ion channel/membrane protein regulation in human cardiac automaticity. Findings from this work will provide the very first insights into the unrecognized roles of ankyrin-B as a regulator of sino-atrial node (SAN) response.